Lumicks C-Trap Optical Tweezers with Confocal Fluorescence Microscope

Title: Lumicks C-Trap optical tweezers with confocal fluorescence microscope.
PI: Bennett Van Houten, PhD
Abstract
This proposal requests the purchase of a Lumicks C-trap correlative single-molecule and force microscope,
which consists of four optical traps, and a 3-color confocal fluorescence platform for Major and Minor user
groups at the University of Pittsburgh and Carnegie Mellon University. The C-trap is the only commercially
available instrument that fully integrates laser traps with confocal microscopy. Single molecule analysis has
helped revolutionize the field of protein-DNA interactions and each of the users have a focused funded project
that would be greatly facilitated by access to this instrument. Through a lease agreement we have been using
the instrument since Feb of 2021 and several user groups have successfully generated preliminary data on the
instrument with up to three different fluorescent proteins. This instrument represents the first placement of this
novel technology within the entire Common Wealth of Pennsylvania, and the new four laser trap module is
planned to be added June 2022 to keep up with this cutting-edge technology. The C-trap allows investigators
to use biophysical approaches to interrogate protein-DNA interactions and follow molecular motors and
assembly of protein machines at specific sites on DNA. This instrument combines several unique features that
makes single molecule and force measurements accessible to wide group of users that might be relatively new
to the single molecule field. The instrument has an automated microfluidic system with a five chamber imaging
flow cell, which provides a wide variety of experimental designs. The instrument is fully temperature controlled
so kinetics of protein-DNA interactions can be followed at different temperatures. The laser traps have high
temporal and spatial control and can measure down to sub pN forces accurately. The force measurements are
real-time correlated with the confocal scanning which can scan at speeds up to 5 msec per scan allowing to
capture rapid single molecule kinetics. The software that controls the instrument and allows data analysis is
easy to use through a Python user interface. Scripting of experimental work-flow as well as data analysis
allows highly reproducible conditions to be established. The two user groups consists of members of the
Genome Stability and Cancer Virology Programs at the UPMC-Hillman Cancer Center, where the instrument is
housed, as well as other minor users throughout the campus. These groups are interested in the role of DNA
damage and repair in cancer and neurodegenerative diseases, as well as how specific viruses can cause
cancer. Five Major users have been identified for the purpose of this application and they in turn have
requested a majority of the time. The five Minor users will work on the instrument in the remaining time. The
Lumicks C-trap is being managed as a user facility at the Hillman Cancer Center and will afford the capacity for
advanced single molecule and mechanical force measurements and will ensure sustained and efficient use by
faculty working in the biomedical sciences in Pittsburgh

Public health relevance
Title: Lumicks C-Trap optical tweezers with confocal fluorescence microscope. PI: Bennett Van Houten, PhD Narrative: The goal of this proposal is to purchase a Lumicks C-trap correlative single-molecule and force microscope that will allow scientists to examine protein-DNA interactions at the single molecule level. Many human diseases are caused by defects in proper assembly and action of mutant proteins on DNA. This instrument will greatly enhance biomedical research in the areas of cancer, neurodegeneration and virology in Pittsburgh, and the Common Wealth of Pennsylvania